Development, Optimization and Preclinical Modeling of Hematopoietic Stem Cell Gene Editing for the Treatment of RAG1 Immunodeficiency

PROJECT SUMMARY
Hematopoietic Stem/Progenitor Cells (HSPC) gene therapy has provided clinical benefits in several patients
affected by a variety of genetic diseases, some of which already reached market authorization for selected
indications. However, the use of semi-randomly integrating vectors poses the risk of insertional mutagenesis and
ectopic/unregulated transgene expression. These issues become even more relevant when the affected gene
needs to be highly express to exert its function and when its activity directly impacts genome stability, such as
the case for Recombination-Activating 1 (RAG1) gene. RAG1 is express in a high but tightly regulated manner
in differentiating lymphocyte precursors, where it directs the VDJ recombination process required for assembly
the T- and B-cell receptors, and its inactivating mutations are one of the most frequent causes of severe-
combined immunodeficiency (SCID). While the high risk of genomic damage due to unregulated RAG1
expression has so far hampered the use of viral vectors to treat RAG1 deficiencies, there is a need to develop
novel and effective therapeutic approaches, especially for patients who lacks a compatible HSPC donor or are
not eligible for allogeneic transplant. The long-term goal of our proposal is to address this unmet medical need
and develop an effective novel treatment directed at restoring both function and expression control of
the RAG1 gene on autologous patient derived HSC. Our central hypothesis is that gene repair strategies that
preserve physiologic expression control represent a safe and effective approach for treating RAG1 deficiencies.
We reported that by tailoring culture conditions and gene delivery vehicles, it is possible to partially overcome
the biologic barriers that constrain gene editing in the most primitive and clinically relevant HSPC subsets
(Genovese, Nature 2014; Schiroli, Science-Translational-Medicine 2017). Within this project we will capitalize
our previous achievements to i) directly fix RAG1 mutations, ii) improve efficiency of current HSPC gene editing
protocols and iii) investigate non-genotoxic conditioning on suitable mouse models. Functional correction of the
engineered RAG1 gene will be stringently assessed on patient derived cells, by exploiting state-of-the-art in vitro
T cell differentiation assay and in vivo xenotransplantation experiments. We will take advantage of our recently
optimized gene editing procedure and barcoding technology (BAR-seq, Ferrari et al, Nat. Biotech. 2020) to
maximize editing efficiency while reducing cellular toxicity on the treated HSPC, thus increasing the yield of long-
term engrafting lymphoid cells. To support the rational for clinical testing, we will assess correction of the disease
phenotype by limiting amounts of functional HSPC in two RAG1 murine models and test efficacy of emerging
immunotoxin conditioning regimens to reduce transplant toxicity and increase lymphoid reconstitution. Overall,
this project will contribute to the development of an innovative treatment approach for RAG1 deficiencies and
position homology-based gene editing as a standard for precise HSC engineering, providing for safer and more
efficacious therapeutic strategies with broad applicability in hematology.

Public health relevance
PROJECT NARRATIVE The main objective of this proposal is to develop a site-specific gene editing strategy for the treatment of primary immunodeficiency caused by mutations into the tightly regulated RAG1 gene. This disease represents an ideal candidate for the new gene correction strategy because preclinical studies of Hematopoietic Stem Cells (HSC) gene therapy have already shown i) evidence of potential efficacy even with few amounts of functionally corrected cells; ii) critical safety issues due to ectopic and unregulated transgene expression from conventional integrating vectors. Here we will overcome this hurdle by exploiting nuclease mediated homologous recombination to directly fix RAG1 mutations and restore both its function and expression control, thus providing the ultimate solution for the treatment of RAG1 patients and opening new avenues for HSC gene editing based therapies.